Revealing the RNA foundations of chromatin-based epigenetics

PROJECT SUMMARY
The goal of this proposal is to determine how the crosstalk between RNA and chromatin shapes epigenetic
states in pluripotent and differentiated cells.
My laboratory studies epigenetic memory, both at a mechanistic level, using biochemistry and functional
genomics in mouse embryonic stem cells, and at an organismal level, using ants and flies as model systems.
In the nine years since the lab opened, our mechanistic work has been recognized for our contributions to
understanding the role of protein–RNA interactions in chromatin regulation and in particular the Polycomb
pathway. We have developed technologies to map RNA-binding sites on specific protein complexes or the
entire proteome using photocrosslinking and mass spectrometry, and used this information to dissect the
functional contribution of RNA to epigenetic pathways. We also established an acute depletion system in
embryonic stem cells that allow us to interrogate epigenetic dynamics during cell fate transitions.
In the next five years, we will build on these studies and develop new systems and technologies to obtain a
deeper understanding of the RNA foundations of chromatin regulation and epigenetic phenomena in
mammalian cells. Using a directed differentiation system from embryonic stem cells to neurons combined with
acute protein and RNA depletion technologies, we will determine the order of biochemical events that
culminate in Polycomb-mediated silencing and the role of RNA at two critical steps: Polycomb target
selection and gene repression via Polycomb body formation. Expanding on our protein–RNA studies with
mass spectrometry, we will study more broadly the role of different classes of RNA and their chemical
modifications in chromatin factor recruitment and design separation-of-function mutants using a newly
developed high-throughput mutational screening method. Finally, we will follow up on some intriguing
preliminary findings from a genome-wide knockout screen to explore a new direction, the molecular
mechanism by which mobile RNAs are selected for incorporation into extracellular vesicles and transfer to
recipient cells, where they might exert epigenetic functions.
This work will add to our mechanistic understanding of RNA-mediated regulation of chromatin processes,
which in turn will provide new opportunities to decode and engineer epigenetic states, with broad impact on
research, biotechnology, and medicine.

Public health relevance
PROJECT NARRATIVE Epigenetic processes provide a layer of regulation that is above the genetic sequence and are essential to understand health and disease. In model organisms, such as yeast and flies, noncoding RNAs play important role in regulating the flow of epigenetic information, but their contribution to these processes in mammals remains poorly understood at a mechanistic level. We will leverage our expertise in RNA biochemistry, functional genomics, and mass spectrometry to identify and characterize RNAs that shape transitions in epigenetic states that accompany the differentiation from embryonic stem cells to neurons.